A community-based participatory approach to addressing sexual and reproductive health services for rural Black female adolescents and young adult females in Alabama

Project Summary
Adolescents and young adults 15-29 years are twice as likely to be infected with HIV and twice as likely to be
infected with a sexually transmitted infection (STI) as the average Alabama resident. These statistics
emphasize the urgency for sexual and reproductive health services (SRHS) interventions with Black
adolescent and young adult females in Alabama, especially those historically underserved who live in
impoverished and rural, isolated areas. The goal of the study is to use participatory and empowerment
approaches to achieving health equity in HIV prevention for young rural Black females in Alabama. Our study
objective is to assess the SRHS experiences (including HIV testing, pre-exposure prophylaxis access) of rural
Black females in Alabama and to initiate intervention planning with the Ending the HIV Epidemic-Alabama
(EHA) Advisory Committee to reduce new HIV infections among young Black females. In Aim 1, we will
examine rural Black females’ SRHS lived experiences across generations using a participatory qualitative
method, Photovoice. We will recruit 30 rural Black mothers and their adolescent daughters (aged 13-17) and
40 rural Black young adult females (aged 18-29). Photovoice includes study participants taking photos and
describing how the photo reflects personal and community strengths and challenges--the photos will capture
the strengths and challenges of SRHS in rural Alabama. They will also complete an online survey to broadly
assess SRHS (including HIV testing, PrEP access). In Aim 2, we aim to identify problems and develop a plan
(i.e., intervention) to resolve the problem of persistent HIV disparities among young rural Black females using
the Soft Systems Methodology (SSM) approach with the EHA committee. SSM is a participatory method that
involves multiple systems (e.g., EHA, individuals, institutions) to identify the root causes of the problem and
collectively generate an action plan (intervention) for resolution. This will be a 5-day workshop in which we will
incorporate the SSM 7-step process. This participatory process will include the EHA determining the level of
intervention (individual, institutional, policy, etc.) and meeting routinely with the principal investigator in Year 2
for design and implementation planning. The results will be used to develop an evaluative implementation
science proposal for the EHA’s implemented plan of action (intervention). This proposed study is in response
to PA-20-272: Administrative Supplements to Existing NIH Grants and Cooperative Agreements (Parent Admin
Supp Clinical Trial Optional), specifically for supporting the Ending the HIV Epidemic (EHE) in the United
States Initiative.

Public health relevance
Public Health Relevance The proposed study will use a mixed methods action research (MMAR) approach to promote community engagement in all aspects of understanding the persistent HIV disparities among young rural Black females and will catalyze a community action plan (intervention) to increase HIV testing and pre-exposure prophylaxis access for historically underserved populations of rural Black females in Alabama. This project will produce generational insights into sexual and reproductive health experiences for rural Black females in Alabama, and the participatory nature of the study will foster a stronger sense of community ownership in resolving HIV infection inequities that burden rural communities and that support two key pillars of the Ending the HIV Epidemic Initiative, diagnose and prevent.